FY25 FACILITIES TO G CONSTRUCTION OF BMP STRUCTURES FOR MDE STORM-WATER COMPLIANCE

This project will design two Best Management Practice (BMP) Stormwater
Management (SWM) structures at Building 350 and Building 549 to bring the
NCI-Frederick in compliance with the Memorandum of Understanding
between the NCI-Frederick and the U.S. Army Garrison.